IOP and Cerebrospinal Fluid Pressure-related Risk Factors for Glaucoma

ABSTRACT
Glaucoma is a leading cause of permanent vision loss worldwide, but the mechanisms of damage are not fully
understood. The retinal ganglion cells (RGC) and their axons transmit visual information from the retina to the
brain, and these axons pass out of the eye through the scleral canal at the optic nerve head (ONH), which is
spanned by a fenestrated connective tissue structure known as the lamina cribrosa (LC). The preponderance
of evidence suggests that the RGC axons are damaged in the laminar region of the ONH in glaucoma. One of
the most consistent glaucoma risk factors is elevated intraocular pressure (IOP), although the “safe” IOP
threshold varies widely among individuals. While there is some evidence that IOP fluctuations contribute to
glaucoma, prior studies have been hampered by the absence of continuous IOP measurement. Retrobulbar
cerebrospinal fluid pressure (CSFP) surrounding the optic nerve partially counteracts IOP at the LC through
the translaminar pressure (TLP=IOP-CSFP). Retrospective clinical studies have suggested that higher CSFP
(and low TLP) is protective for glaucoma and low CSFP (and high TLP) increases glaucoma risk, after
accounting for the effects of IOP. In addition, since the LC bears the bulk of the pressure load in the ONH due
to its high stiffness relative to the surrounding neural tissues, LC thickness plays a critical role in the
distribution of TLP in the ONH via the translaminar pressure gradient (TLPG = TLP/LC thickness), adding a
morphological component to TLP. Hence, the goal of this project is to test the hypotheses that IOP, TLP, and
TLPG fluctuations independently contribute to eye-specific susceptibility to glaucoma onset and progression
after accounting for differential mean IOP in fellow eyes, and confirm the recent finding that CSFP and IOP are
coupled via neural pathways. In this project, we will perform mechanical compliance testing to quantify LC
deformations in vivo in response to controlled acute TLP challenge, in an animal model of unilateral glaucoma
instrumented with continuous IOP, CSFP, TLP, and TLPG telemetry. We will then determine the relationships
between axonal and visual function loss per unit of differential mean IOP in fellow eyes and 1) transient and
diurnal IOP fluctuation, 2) TLP and TLPG (mean and fluctuation) and 3) LC deformations in response to acute
TLP challenge, measured while the eye is normal and after glaucoma onset and progression. Impact: If results
show that IOP fluctuations, TLP and/or TLPG contribute to glaucoma pathogenesis and progression in addition
to mean IOP, new therapeutic approaches could be developed to modulate these factors to treat glaucoma.

Public health relevance
PROJECT NARRATIVE Glaucoma is a leading cause of blindness and optic nerve head (ONH) biomechanics are thought to play an important role. We will use continuous intraocular pressure (IOP), cerebrospinal fluid pressure (CSFP) and translaminar pressure gradient (TLPG) telemetry, along with in vivo measurements of TLP-induced ONH deformations, to determine if IOP fluctuations, and CSFP or TLPG contribute to the eye-specific susceptibility to glaucoma onset and progression, and if IOP and CSFP are coupled via neural pathways. The knowledge gained from these studies will drive future development of glaucoma diagnostics and new therapeutic strategies.